Using AI on Routine Clinical and Imaging Data from Acute Stroke Encounter to Predict Post-Stroke Vascular Contributions to Cognitive Impairment (AI - RESPECT)

Project Summary
Poststroke cognitive impairment (PSCI) was found to be common in various research studies. PSCI is ideally
recognized through cognitive screening and test but they are not standard clinical practices and hence stroke
recovery and prevention of recurrent strokes may be undermined by concurrent but poorly recognized
cognitive issues, e.g., patient compliance to follow blood pressure control medication may be poorer among
those with PSCI. Therefore, a significant unmet need for optimizing poststroke care is to recognize patients at
high risk of PSCI to tailor for them an appropriate stroke recovery and recurrent stroke prevention strategy.
With many of the plausible determinants of PSCI being available in electronic health record (EHR) systems,
machine learning (ML) methods to process routine clinical data to predict risk of PSCI is highly feasible. In the
parent project, we will combine a large retrospective dataset from EHR and a smaller prospective dataset with
more accurate ascertainment of PSCI based on purposefully administered cognitive tests, serving as gold-
standard. The necessity of prospective cognitive tests to accurately ascertain PSCI further allows us to explore
biological and physiological variables related to pathologies of Alzheimer disease and related dementia
(ADRD). We will pursue three specific aims in the parent project: 1) Learn to predict PSCI using routine neuro
images and EHR data from large clinical cohorts; 2) Use prospective data to adapt and validate models
learned from existing clinical cohorts; 3) Phenotype PSCI with cognitive tests, physiological, and biological
metrics one-year poststroke. In the supplement project, we will conduct APOE genotyping of all prospectively
enrolled subjects, measure ~120 protein biomarkers, in addition to pTau217 and NfL, of neuronal injury,
amyloid tau pathologies, inflammation, vascular and metabolism, synuclein and synaptic disorders, and
neurodegeneration. Our specific aim for the supplement project is to enrich AI approaches to predict and
understand post stroke cognitive impairment with APOE genotyping and multi-pathology plasma-
based protein biomarkers.

Public health relevance
Project Narrative Post stroke cognitive impairment (PSCI) is a frequent complication experienced by stroke survivors and yet there remain gaps in both fundamental knowledge of how cerebral vascular contributions to dementia interact with likely preexisting neurodegenerative burdens among stroke survivors and practical decision support tools to aid in clinicians in prognosticating and managing PSCI to optimize stroke recovery and prevention of recurrent stroke. This project addresses these two gaps by developing novel machine learning algorithms to process a large and ethnically diverse routine clinical neuroimage and electronic health record dataset to predict PSCI and also assess, through a prospective study, added benefits of APOE genotyping, novel physiological and biological metrics of cerebrovascular, neurodegenerative, amyloid beta pathologies, synaptic, and inflammation underpinnings.